Nutrient Sensing and Signaling in Metabolism

Project Summary/Abstract
The specific aims of this FASEB Science Research Conference are to present and discuss the most current
work on 1) the critical roles of nutrients and metabolism in mediating development and aging, 2) how nutrient
sensing and signaling are improperly regulated in diseases, 3) innovative experimental approaches and tools
to measure and manipulate metabolism and, 4) how altering nutrient sensing and signaling can be leveraged
as potential therapy. This meeting will be the tenth in a series which has for the past 30 years successfully
promoted interdisciplinary discussion and collaboration among research scientists and physician-scientists in
fields related to obesity, diabetes, nutrition, and exercise across the life span. This meeting continues its proud
legacy of encouraging the attendance and participation of scientists who are Early-Stage and/or
underrepresented in biomedical research. 23 established investigators and 13 Early-Stage investigators will
serve as invited speakers. Poster sessions will permit all participants to contribute, and an additional poster
competition will provide special attention and recognition for research efforts by trainees. Dr. Scot Kimball,
PhD, an international expert in nutrient sensing and signaling in metabolism, will deliver a keynote address on
skeletal muscle signaling and metabolism, followed by a session on the interaction of nutrients and exercise in
maintenance of skeletal muscle metabolic homeostasis. Eight additional sessions will broadly address current
topics in nutrition and metabolism in a variety of body tissues and the microbiome, all aimed toward prevention
or treatment of metabolic diseases such as obesity, diabetes, sarcopenia and cachexia. Every session also
includes speaking opportunities for abstract submissions and poster competition winners. A career
development panel for trainees is included in the agenda and financial support for family care will also be
available. The total number of participants will be limited to 200 to encourage interaction and increase the
opportunity for trainees to meet and discuss research with senior scientists. The five-day meeting will be held
August 4-8, 2024, in Southbridge, Massachusetts.

Public health relevance
Project Narrative This application seeks funding to support the attendance and participation of emerging investigators and those underrepresented in the sciences at the 2024 Federation of American Societies of Experimental Biology Science Research Conference on “Nutrient Sensing and Signaling in Metabolism”, held in Southbridge, Massachusetts on August 4-8, 2024. The main objective of this meeting is to promote interdisciplinary discussion and collaboration among research scientists and physician-scientists in fields related to obesity, diabetes, metabolic dysregulation, and nutritional aspects of disease across the life span.